FIFTEENTH, SIXTEENTH &SEVENTEENTH ANNUAL MBRS SYMPOSIUM

This Proposal is a request to organize and manage the 1987, 1988, and 1989 MBRS Symposia. The tentative sites selected for each of these years are Washington, D.C., San Francisco or Los Angeles, and San Antonio or Atlanta, respectively. The organizational structure for these Symposia calls for the utilization of the services of specialized conference service contractors, and the utilization of a newly formed National MBRS Symposium Program Committee. The anticipated results of this organizational plan is a more pleasing set of conferences that are delivered at a lower cost to NIH.